Ultrashort Echo Time Magnetic Resonance Imaging of the Knee Joint

7. Abstract
Knee osteoarthritis (OA) affects >14 million Americans. It is important to develop techniques to assess
early OA for timely intervention. MRI provides excellent soft tissue contrast, but clinical MRI is insensitive to
early OA. There are four major barriers: First, OA is a "whole organ disease" that involves all major joint
tissues, but many joint tissues (e.g., the deep cartilage, menisci, ligaments, tendons, and bone) have short T2s
and show little or no signal with clinical MRI. Second, early OA is associated with proteoglycan (PG) loss and
collagen disruption, which are difficult to evaluate especially for short-T2 tissues. Third, most research has
focused on T2 (biomarker of collagen disruption) and continuous wave T1 (CW-T1) (biomarker of PG
depletion). However, T2 and CW-T1 are sensitive to the magic angle effect with >100% increase when tissue
fibers are reoriented from 0 to ~54 to B0 (exceeding the 10-30% change produced by OA). Fourth, MRI is
slow and expensive, requiring fast imaging to reduce cost and automated processing to facilitate clinical
applications. There is an urgent need for fast automated angular-independent biomarkers to map PG and
collagen in both short- and long-T2 tissues in the knee joint to diagnose early OA accurately.
Ultrashort echo time (UTE) sequences can image "MR invisible" tissues. UTE adiabatic T1 (UTE-
Adiabatic-T1) and magnetization transfer modeling of macromolecular fraction (UTE-MT-MMF) allow magic
angle insensitive mapping of PG and collagen in all major knee joint tissues. Fat is a major confounding factor.
It has significantly shorter T1 and higher proton density than most short-T2 tissues, leading to high fat signal
and low short-T2 contrast in UTE imaging. Fat also produces strong chemical shift artifacts manifest as spatial
blurring and ringing artifacts in non-Cartesian UTE imaging, leading to inaccurate quantitation. Fat saturation
(FatSat) can reduce fat signal and chemical shift artifacts. However, FatSat pulses may significantly suppress
short-T2 signals directly due to their broad spectra or indirectly due to the MT effect. UTE with a soft-hard
composite pulse allows water excitation with little chemical shift artifact. Single point Dixon technique allows
robust fat water separation without short-T2 signal attenuation. These techniques can be combined with UTE-
Adiabatic-T1 and UTE-MT-MMF to improve PG and collagen mapping. Furthermore, quantitative UTE imaging
is time-consuming and involves complicated data processing and signal modeling. Deep learning (DL) allows
automatic segmentation and accelerated quantitative mapping. This proposal aims to optimize and validate
UTE-Adiabatic-T1 and UTE-MT-MMF techniques on knee specimens for early OA (Aim 1), develop a multi-
tissue segmentation with multi-parameter quantification net (MSMQ-Net) for simultaneous segmentation and
multi-parameter mapping (Aim 2), and evaluate knee changes before and post (6, 12, and 24 months)
meniscectomy for proof of principle (Aim 3). The goal is to deliver a validated postprocessing pipeline from
image acquisition to automated segmentation and UTE mapping of all major knee tissues for early OA.

Public health relevance
8. Project Narrative This proposal aims to optimize and validate UTE-Adiabatic-T1 and UTE-MT-MMF techniques on knee specimens for early OA using histopathology, biochemistry, and biomechanics as reference standards (Aim 1), develop a multi-tissue segmentation with multi-parameter quantification net (MSMQ-Net) for simultaneous segmentation and multi-parameter mapping of all major knee joint tissues (Aim 2), and evaluate knee changes before and post (6, 12, and 24 months) meniscectomy for proof of principle (Aim 3). The goal is to deliver a validated postprocessing pipeline from image acquisition to automated segmentation and UTE mapping of all major knee tissues for early OA.